Innate and Adaptive Immunity in the Pathogenesis of Glaucoma

ABSTRACT
In responding to the PA-20-272 that calls for Alzheimer's-focused administrative supplements for NIH
grants that are not focused on Alzheimer's Disease (AD), this application proposes to expand on the
existing award (5 R01 EY031696-02) to the identification of novel pathogenesis and biomarkers of AD.
There is, at present, no established cure or disease-modifying treatment for AD, largely due to the lack of
clear understanding of the disease pathogenesis. The eyes provide a window into many aspects of brain
function and health. Extensive eye-related complications have been observed in AD. These include the
loss of retinal ganglion cells (RGCs) and thinning of the retinal nerve fiber layer (RNFL), the main cell type
affected in glaucoma. Emerging evidence also suggests an overlap between the molecular mechanisms
of glaucoma and those of AD. We recently reported a novel immune component involving systemic T cell
responses underlying the pathogenesis of glaucoma, that signifies a paradigm shift concept in
neurodegeneration. We demonstrated that chronic neurodegeneration in glaucoma is critically associated
with the induction of systemic responses of CD4+ T helper 1 (Th1) cells specific to heat shock proteins
(HSPs). Acute insults and stress to neurons, such as those associated with ischemia, injury, or elevated
intraocular pressure, evoke microglial activation that initiates HSP-specific T cell responses to contribute
to a prolonged phase of neuron loss. Moreover, data acquired through the current award (EY031696)
showed further that not only patients with primary open angle glaucoma exhibited significantly increased
frequencies of HSP-specific T cells in the peripheral blood compared to control subjects, but the HSP-
specific T cell counts correlated with the thinning of RNFL. These results demonstrate the human relevance
of a systemic T cell-mediated mechanism in glaucomatous neuronal damage. Accumulating evidence
showed that peripherally activated CD4+ T cells could enter the CNS with an intact blood-brain-barrier.
Together, these have led to the extension of our hypothesis that the similar immune mechanism involving
systemic T cell responses in glaucoma is at the play to perpetuate neurodegeneration in AD. We therefore
propose to expand the current studies to critically examine the roles of HSP-specific Th1 cells in animal
models and human patients with AD. We will ask: (1) if mice and human patients with AD exhibit increased
HSP-specific T cell frequencies in the peripheral blood compared to controls, and (2) if adoptive transfer
of HSP-specific T cells taken from AD mice exacerbates AD pathology in the recipient mouse brains. The
proposed studies may uncover novel insights into AD pathogenesis, and identification of peripheral blood
and serum biomarkers may lead to new diagnostic method for screening individuals at risk for AD and/or
monitoring disease progression.

Public health relevance
Project Narrative As no established cure or disease-modifying treatment is available for Alzheimer's disease (AD) due to the lack of clear understanding of the disease pathogenesis, this proposed study aims to test the hypothesis that neurodegeneration in patients with AD is mediated, at least in part, by an immune mechanism involving systemic T cell responses. The results may uncover novel insights into the disease development and progression and identify accessible blood biomarkers that may lead to new treatment as well as diagnostic method for screening individuals at risk for AD and/or monitoring disease progression.